Investigating Habitual Behavior and Dopamine Dysregulation in Tourette Syndrome

Abstract: Tourette Syndrome (TS) is a neurodevelopmental disorder characterized by urges to perform tics
which are repetitive, stereotyped, and uncontrollable movements or sounds. The CDC estimates that TS and
related chronic tic disorders affect ~1 in 50 children. Despite the high prevalence, the underlying neuropathology
is poorly understood. A lack of preclinical animal models is a large reason for this current impasse in TS research.
This grant proposes a new way to overcome this barrier using novel mouse models generated in our lab that
express orthologous human mutations identified in a high-confidence TS gene, CELSR3. Preliminary data shows
these mice exhibit tic-like stereotypies in the open field, with sex-dependent variable expressivity, and also
changes to striatal dopamine. Leveraging these novel mice with construct and face validity, I will test the
hypothesis that tics are associated with changes to habit formation and dopamine signaling. Habits and tics are
highly similar: they are both repetitive, stereotyped, and automated actions that once formed are hard to break.
It is proposed in TS that a potentiation of sensorimotor inputs onto striatal circuits regulating habit formation
along with potentially weaker engagement of circuits controlling goal-directed behavior may predispose
individuals to develop ‘tic-habits’. Further, ‘tic-habits’ may be perpetuated by aberrant DA signaling, which
reinforces and motivates these learned behaviors. Human studies have demonstrated that TS probands develop
habits quicker, an effect not seen in medicated probands on DA stabilizers (aripiprazole). Additionally, habit
reversal therapy is proven to help decrease tics in ~40% of TS subjects, further suggesting a link between habits
and tics. However, these findings have yet to be tested and confirmed in animal models, and the
neurodevelopmental circuit changes regulating habit formation in TS remain uninvestigated. Similar to human
findings, my preliminary data suggests Celsr3 TS mice form habits faster and have difficultly breaking them (akin
to difficulty seen in ceasing to tic). Interestingly, some tic-like stereotypies are more pronounced in female mice,
suggesting sex-differences need to be explored. Thus, I hypothesize Celsr3 TS mice will demonstrate enhanced
habitual responding and changes to DA signaling during early stages of habit formation, which may be influenced
by sex. I also hypothesize that these phenotypes will be normalized with aripiprazole, as observed in human
subjects. In Aim 1, I will use instrumental learning paradigms to test if habit formation and goal-directed behaviors
are enhanced and/or weakened, respectively. Deciphering potential circuit imbalances between these two
systems will provide insight into neurodevelopmental circuit changes proposed in TS. In Aim 2, I will use in vivo
imaging and fiber photometry to investigate DA signaling while mice form habits. I will also administer aripiprazole
to test if I can normalize habitual behavior to control levels. These experiments will be the first to investigate
habit formation and DA dysregulation in TS using bona fide TS mouse models with true construct and face
validity. These results will help explain the neurobiological basis of tics, helping to improve treatment strategies.

Public health relevance
Project Narrative Tourette Syndrome (TS) is a highly prevalent neurological disorder in which the underlying neuropathology still remains poorly understood and under investigated. This grant proposal will utilize novel preclinical mouse models expressing orthologous human mutations in high-confidence TS genes to investigate the underlying circuit mechanisms of TS. These experiments will begin to reveal the uninvestigated neuronal substrates of habit formation and dopamine dysregulation hypothesized in TS, as well as aid in future research for improving therapeutics/interventions for TS.